Genetic architecture of host response to tickborne disease in Peromyscus leucopus

PROJECT SUMMARY (Administrative supplement)
For the administrative supplement a fourth specific aim is added to the project: Functional
consequences of naturally-occurring genetic variants for responses of Peromyscus to Borreliella burgdorferi.
The parent project principally entails forward genetics approaches to identify the traits and ultimately
characterize the mechanisms for the white-footed deermouse's capacity to serve as a major reservoir for
several zoonotic agents, including the cause of Lyme disease, while maintaining fitness in the presence of
persistent infection. In the course of the project to date, we have made discoveries that justify a new line of
investigation that takes a reverse genetics approach. The discoveries represent both innate and aquired
immunity in Peromyscus immunity: (1) Structural variants in the Nos2 gene of P. leucopus populations that
could account for an attenuated production of nitric oxide and reactive nitrogen species during infection. (2)
Evidence in Peromyscus of an inactivated Fcgr1 gene that encodes the high-affinity IgG Fc receptor protein
(FcγR1 or CD64) of macrophages and other phagocytes. (3) An association between a MHC class II gene
and the antibody response to the OspA protein of Borreliella burgdorferi. The new aim comprises four sub-
aims: (A) host response phenotypes of variants of the Nos2 gene and its 3’-UTR in P. leucopus, (B) functional
effects of mutant Fcgr1 of Peromyscus, (C) variation of MHC II genes and antibodies to OspA after
immunization, and (D) high-throughput discovery and annotation of structural variants segregating in the
colony. The new research supported by this administrative supplement is anticipated to have both basic
research and translational research and application impacts. The findings may also guide clinical research on
persisting illness in patients with Lyme disease and other tickborne infections.

Public health relevance
Project Narrative Lyme disease is caused by a tick transmitted bacteria (B. burgdorferi), but must pass through a rodent host to complete its life cycle. P. leucopus is the preferred rodent host for this and other vector borne diseases. Genome wide association studies in P. leucopus will identify and validate (via Cas9-based knockouts) genes that mediate the compentency of P. leucopus to serve as a host for B. burgdoreri and other disease causing agents. Genes may suggest treatment options and/or strategies to slow disease spread.